EFFECT OF ANDROGEN EXCESS ON COGNITIVE FUNCTIONING IN WOMEN

The purpose of this study is to determine whether elevated androgen levels influence cognitive functioning in adolescent and adult females with hyperandrogenism in comparison to matched control females with normal hormone levels. The following cognitive abilities will be evaluated: 1) spatial ability, 2) verbal fluency, 3) perceptual speed and accuracy, 4) fine motor skills, 5) attention, and 6) memory.